New multi-modal ultrasound imaging methods for longitudinal analysis of tissue healing and early prognosis

ABSTRACT
This project aims at developing novel multi-modal imaging methods that can be used as predictive makers of
tissue healing and to non-invasively monitor the tissue healing response. The proposed imaging methods are
based on the use of safe, cost-effective and non-invasive ultrasound imaging methods. The acquisition of
ultrasound signals from the tissue area of interest is typically fast and does not require anesthesia, radiations, or
imaging contrast. Theoretical models and software techniques are then used to obtain images and
measurements of the healing tissues. Ultrasound scanners are available worldwide, and the availability of small
portable ultrasonic devices allows for prompt assessment “in the field” where other imaging methods may not be
readily available.
In this study, we propose to investigate new prognostic markers of tissue healing related to vascular and
interstitial fluid transport mechanisms. In addition to biomechanical understanding of tissue regenerative
mechanisms, these properties are important to assess the propensity of tissue healing and likely outcome of
tissue repair. These prognostic markers are used in conjunction with novel 3D imaging methods to track spatial
and temporal changes occurring in the healing tissues over time.
Availability of these non-invasive, real-time and cost-effective imaging technologies can benefit several medical
fields, such as oncology, cardiology, orthopedics and regenerative medicine. By providing new information about
the mechanical, physical and biological behavior of newly formed tissues in vivo, the methods included in this
proposal can be used as new tools to better understand tissue repair mechanisms and may be useful for guiding
and monitoring treatments that can deliver effective and personalized care.

Public health relevance
Narrative The goal of this research is to develop novel and non-invasive ultrasound-based imaging tools that can be used to assess early signs of tissue healing. This information may lead to quantitative methods to assess and monitor tissue healing for improved and personalized care. Its availability using cost-effective and easily deployable imaging methods may have a large impact on tissue regenerative applications and other medical areas.